Wisconsin Expanded Program Occupational Health Surveillance Project

State Occupational Safety and Health Surveillance Program (U60) PAR-20-312
Wisconsin Occupational Health Surveillance Expanded Program
Project Summary
Wisconsin’s partnership since 1984 with National Institute for Occupational Safety and Health
(NIOSH) has enabled the Occupational Health (OH) Program to develop the capabilities,
partnerships, and capacity to reduce occupational injuries and deaths in Wisconsin and
contribute occupational health data to the national surveillance system. Wisconsin’s OH
Program activities meaningfully advance NIOSH priorities, National Occupational Research
Agenda (NORA) priorities, Healthy People 2030 objectives, and Wisconsin’s health
improvement plan. The Expanded Program has three specific aims: 1) Continue and expand
Wisconsin’s occupational illness, injury and death surveillance activities; 2) Disseminate
Occupational Health information to Wisconsin stakeholders and national partners; 3) Identify,
develop and promote public health interventions to improve occupational health and safety.
Three expanded projects are proposed: Enhancement of Occupational Surveillance through
Electronic Case Reporting and Data Capture; Surveillance, Epidemiology, and Prevention of
Occupational Infectious Diseases; and Occupational Respiratory Disease Surveillance.
Continued funding will allow the Wisconsin OH program to expand population and individual
based surveillance data to yield important information about trends, injury clusters, and
emerging issues that will support effective, science-based interventions for targeted worker
populations, especially those most at risk for injury or illness. The proposed Expanded Program
will use and improve Wisconsin’s occupational health surveillance data systems to identify
trends in incidence and prevalence of occupational injuries, deaths, and exposures; establish
annual priorities; and develop and disseminate public health recommendations for occupational
health interventions to reduce the incidence of work-related injuries and illnesses in Wisconsin.

Public health relevance
State Occupational Safety and Health Surveillance Program (U60) PAR-20-312 Wisconsin Occupational Health Surveillance Expanded Program Project Narrative This surveillance program will increase information on occupational injuries, deaths, and exposures. Information will be used to identify surveillance trends, emerging issues, and high- risk occupations, industries and worker populations to inform development and dissemination of public health recommendations for workplace interventions.